Dopaminergic regulation of aversion-motivated behaviors

Project Summary
Negative experiences influence everyone's daily lives by altering emotional states, decision making, and
motivated behavior. For those with substance abuse disorders attempting to remain abstinent, such experiences
are clinically relevant as they are often described as a primary trigger to relapse. Similarly, negative experiences
can trigger or exacerbate mood disorders such as depression. In order to develop ways to protect against the
detrimental impact of these negative experiences, it is critical to understand the neural mechanisms by which
aversive stimuli affect motivation. Decades of research has shown the nucleus accumbens (NAc) to be a key
region for affective processes to impact behavior. Thus, it is important to understand how negative experiences
affect mesolimbic dopamine signaling and the impact that has on motivated behaviors. Research from our lab
suggests that aversive stimuli promote drug-taking and also decrease nucleus accumbens dopamine. The
central hypothesis in this proposal is that negative experiences reduce mesoaccumbens dopamine and that it is
this reduction which causes the increased motivated behavior we have seen following exposure to aversive
stimuli.
Aim 1 will test the necessity and sufficiency of aversion-induced dopamine changes to alter escape behavior.
Preliminary data from our lab show that rats will perform an operant response to terminate an aversive white
noise. I will use optogenetics to manipulate dopamine release to both mimic and counteract the typical white
noise-induced reduction in dopamine. Aim 2 will test the necessity and sufficiency of aversion-induced dopamine
reductions to alter drug-taking behavior. Our preliminary data show that white noise both reduces dopamine and
increases drug-taking. This experiment will leverage chemogenetics and photometry to both manipulate and
measure dopamine release during drug self-administration. Aim 3 will test the impact of prior chronic variable
stress on the sensitivity to aversive stimuli. I will use photometry to characterize naturally occurring dopamine
levels following chronic stress, then test if chronic stress also changes the sensitivity to aversive stimuli in a
punishment paradigm.
I am confident that the training and mentorship of Drs. Robert Wheeler, Marieke Gilmartin, and John Mantsch
throughout the research and training aspects of this fellowship will expand on my experimental skills to
successfully complete the proposed research, as well as gain professional skills that will equip me for a
postdoctoral position. This fellowship will thus help me achieve my ultimate goal to develop an independent
research program at an academic institution that also permits me to engage in regular teaching responsibilities.

Public health relevance
PROJECT NARRATIVE Disorders of motivated behavior, such as depression and drug addiction, can be triggered or aggravated by negative experiences. This project will investigate the motivational properties of aversive stimuli and the underlying neurobiological mechanisms. Specifically, the proposed experiments aim to uncover the role of dopamine in mediating aversion-induced changes in drug seeking, negative reinforcement, and punishment learning after chronic stress.